Understanding and Mitigating Vascular Side-Effects Associated with Anti-Amyloid Immunotherapy

PROJECT SUMMARY/ABSTRACT:
Recent FDA accelerated approvals of two anti-amyloid antibody treatments, aducanumab and lecanemab, for
early-stage Alzheimer’s disease (AD) provide the first disease-modifying treatments to date, albeit with modest-
to-moderate slowing of cognitive decline, and potentially fatal vascular side effects known as Amyloid Related
Imaging Abnormalities due to edema (ARIA-E) or microhemorrhages (ARIA-H) in a subset of patients, especially
ApoE4 carriers. A recent press release reported efficacy and ARIA in a Phase 3 trial of donanemab, another
antibody targeting aggregated amyloid- (A) protein. ARIA is mostly asymptomatic and transient but
occasionally causes more severe cortical edema and hemorrhage, which makes understanding and mitigating
ARIA an urgent unmet need as these antibodies move into the clinic. Strong but circumstantial evidence points
to cerebral amyloid angiopathy (CAA), Aβ deposits within the brain vasculature, rather than amyloid plaques, as
a cause of ARIA. Patients with CAA in addition to amyloid plaques are at higher risk of ARIA than patients with
plaques but no CAA. Patients carrying an APOE ε4 allele, which predisposes to CAA and impairs Aβ clearance
across the blood-brain barrier, are also at higher risk than patients with ε3 or ε2 alleles. We hypothesize that
infused anti-amyloid antibodies first encounter and bind vascular amyloid and cause ARIA. Testing this
hypothesis requires determining if antibodies that cause more ARIA (e.g., aducanemab) bind more vascular A,
localize earlier and at higher concentrations to vascular A, and cause more immune activation toward vascular
A than antibodies that cause less ARIA (e.g., lecanemab). APOE is likely to play a role as an anti-APOE
antibody, HAE-4, has been reported to clear both vascular and plaque amyloid while restoring vascular function
(Xiong et al., 2021). Complement fixation of the anti-A antibodies at sites of vascular amyloid may lead to
activation of the complement cascade that results in a proinflammatory response, BBB leakage, edema and
microhemorrhage. Therefore, we hypothesize that combining anti-amyloid antibodies with antibodies targeting
poorly lipidated APOE associated with fibrillar amyloid or complement C1s to block complement activation will
mitigate ARIA and perhaps improve efficacy. We propose the following three Aims: 1. We will compare four
anti-amyloid antibodies (aducanemab, lecanemab, gantenerumab and donanemab) for their binding to plaque
vs. vascular amyloid both biochemically and pathologically. 2. We will define the timing of ARIA and characterize
vascular changes after 2, 4 and 8 weekly treatments with recombinant murine aducanemab, lecanemab and
donanemab in aged 5XE4 mice. 3. We will combine the anti-amyloid antibody most prone to induce ARIA in
Aim 2 with the HAE-4 anti-APOE antibody or an anti-C1s antibody to block the activation of the classical
complement pathway to mitigate ARIA in aged 5XE4 mice. If successful, we will have a mechanism for anti-
amyloid immunotherapy-related ARIA. Combination trials targeting amyloid and APOE or C1s in humans could
be initiated to improve the efficacy and safety of anti-amyloid antibody immunotherapy.

Public health relevance
NARRATIVE: Recent FDA accelerated approvals of aducanumab and lecanemab for early-stage Alzheimer’s disease, and reported positive phase 3 results from donaneab, provide the first disease-modifying treatments to date, albeit with modest-to-moderate slowing of cognitive decline and the presence of potentially fatal vascular side effects known as Amyloid-Related Imaging Abnormalities (ARIA) in a subset of treated patients. Here, we will test our hypothesis that anti-amyloid antibodies with higher binding affinities for vascular amyloid are more likely to cause ARIA by comparing the biological and pathological binding characteristics of 4 clinical anti-amyloid antibodies to parenchymal plaque and vascular amyloid in human AD brain tissues and staining in amyloid mouse models. In addition, we will compare in vivo the ability of the murine analogs of 3 of the anti-amyloid antibodies to both lower plaque and vascular amyloid burden and induce ARIA in 5XE4 mice and, test antibody cocktails containing an anti-amyloid antibodies and either an anti-APOE mAb or an anti-complement C1s1 antibody to mitigate ARIA.